Small molecule therapeutic for calcific aortic valve disease

PROJECT SUMMARY
Aortic valve stenosis is the major cause of valve disease in the Western world, and the third leading cause of
adult heart disease. It is a progressive disorder associated with calcification that worsens with aging, thus is
rising in prevalence as the worldwide population ages. There is an unmet need to develop medical therapeutics
for this condition, as the only treatment for calcific aortic valve disease (CAVD) involves valve replacement. A
major risk factor for calcific aortic valve disease (CAVD) is bicuspid aortic valve (BAV), which is present in 1–2%
of the population, and involves formation of a two, rather than three, leaflet valve. ~35% of individuals with BAV
will develop CAVD with age, but some with BAV display leaflet thickening even in childhood. We have previously
reported that loss-of-function mutations in the NOTCH1 gene cause congenital bicuspid aortic valve (BAV) and
early-onset CAVD. Patient-specific iPSCs and primary aortic valve cells from CAVD patients without NOTCH1
mutations revealed that abnormal cell fate conversion of valve cells into osteoblast-like cells is the underlying
pathogenesis of CAVD. Using a gene network-based small molecule library screen and a machine learning
algorithm, we found the compound XCT790 broadly corrected gene dysregulation in NOTCH1 haploinsufficient
human iPSC-derived endothelial cells. We postulated XCT790 may function to modulate the cell fate conversion
event regardless of the inciting genetic cause as we did not screen for a NOTCH1 agonist; indeed, in primary
aortic valve endothelial cells from explanted patient valves without evidence of NOTCH1 mutations, the
dysregulated gene network was corrected in the vast majority of patient cells. In a mouse CAVD model, XCT790,
annotated to inhibit estrogen-related receptor-a (ERRa), reduced valvular thickening, stenosis and calcification
in vivo, positing this compound as a strong candidate for therapeutic intervention in CAVD patients. A second
ERRa inhibitor, Compound 29, also corrected gene networks and appears to arrest established disease in mice.
Here we will test the hypothesis that XCT790 prevents the progression of CAVD by targeting ERRα, and that
XCT790 or an oral ERRa inhibitor, Compound 29, has favorable pharmacokinetics and toxicity properties for
further drug development. We propose to achieve this by pursuing the following Aims: 1) Identification of the
molecular target associated with therapeutic activity of XCT790/Compound 29 for CAVD; 2) Determine minimal
dosing and optimal route of administration for XCT790 and Compound 29 for treating two independent models
of CAVD; and 3) Evaluate pharmacokinetics and potential toxicities of XCT790 and Compound 29 in vivo. These
studies will test the therapeutic potential of XCT790 and Compound 29, and establish the groundwork for clinical
translation of these drugs to treat a disease that represents an enormous unmet medical need, is characterized
by high mortality and morbidity, and for which the main current remedy is invasive surgery.

Public health relevance
PROJECT NARRATIVE Aortic valve stenosis, a progressive disorder associated with calcification that worsens with aging, is the major cause of valve disease in the Western world, and the third leading cause of adult heart disease. Although there are no current medical therapies, we have discovered a small molecule drug that corrects dysregulated genes in patient valve cells and effectively treats aortic valve disease in mice. In this proposal, we will definitively determine the target of this drug, its optimal dose and route of administration, and associated pharmacologic properties and toxicity in order to advance for clinical development in patients with disease.